Statistical Modeling of Multiparental and Genetic Reference Populations

PROJECT SUMMARY / ABSTRACT
Genetic crosses in model organisms play an essential role in understanding how heritable factors affect medically
relevant traits. Such crosses have traditionally tended to be on a small scale with limited power to detect genetic
effects, limited ability to localize causal variants, and limited options for replication. In the last 15 years, however,
the emergence of larger-scale interdisciplinary research, cheaper genomic technologies, and parallel advances
in human genetics has spurred the development of more sophisticated and powerful experimental designs.
Foremost are those that incorporate two modern genetic design concepts: the multiparental population (MPP),
whereby each subject is descended from a small, well-characterized set of genetically diverse inbred strains,
with the goal of efﬁciently exploring a wide genetic landscape; and the genetic reference population (GRP),
whereby subjects are drawn from a large and genetically diverse set of inbred strains, with the goal that the study
population, and thereby the studies themselves, can be inﬁnitely replicated. Their combination, the multiparental
genetic reference population (MP-GRP), represents the state-of-the-art in complex trait genetics and has been
implemented in a number of model organisms, including plants, ﬂies, and rodents.
The proposed program of research focuses primarily on the development of statistical and computational
tools to advance the design and analysis of studies using MPPs, GRPs, and MP-GRPs, and secondarily on
how those tools can be applied to genetically varying populations more broadly, including humans. Five main
research themes are considered:
1) How to maximally exploit GRPs for studying genetic effects on treatment-response phenotypes, such as
adverse reactions to drug therapy, pathogenesis in response to viral infection, or metabolic response to diet.
Directions considered include new ways to a) statistically deconfound genetic effects on treatment response
from those on baseline outcomes, b) detect genetic effects that are distributional or non-linear in nature.
2) How to use multiple studies on related GRPs to a) assess replicability and reproducibility of those re-
sources, and b) combine analyses for greater power.
3) How to accommodate and exploit genetic- and non-genetically-driven differences in residual phenotypic
variance in QTL mapping and genomic analyses.
4) How to maximally exploit QTL mapping based on haplotypes, both in cases where haplotypes are inferred
based on descent and where they are assigned as pseudo-haplotypes through empirical clustering procedures.
5) How methods for multi-omic causal can exploit haplotype- and pseudo-haplotyped-based genetic anchors.
Progress on these fronts will increase the power, value, and scope of studies on genetically varying model
organism populations as well as on genetically varying populations more broadly.

Public health relevance
PROJECT NARRATIVE (RELEVANCE) The proposed research will lead to improvements in the analysis and design of genetic studies on experimental models of human disease. Because the project focuses on statistical methodology applied to experimental model organism populations, the scientiﬁc output of the project is expected to be applicable to basic research focusing on any medical condition that can be studied in model organisms. In addition, it is expected that a subset of the developed methodologies will be applicable to human genetic data and possible such applications will be considered through interactions with collaborators.